Analyzing effectiveness of ongoing natural experiments in telehealth

PROJECT SUMMARY
Uncontrolled blood pressure (BP) is the most prevalent modifiable risk for cardiovascular disease
(CVD) and disorders directly influencing CVD (e.g., diabetes, chronic kidney disease, etc.). Along with many
other aspects of U.S. healthcare, management of uncontrolled BP was severely disrupted during the COVID-
19 pandemic. In response, many health systems rapidly accelerated implementation of new technologies,
including telehealth visits for BP control and support for self-monitoring with home-based measurement of BP.
Anecdotally, new BP control technologies and strategies have been implemented differentially with wide
variation in timing and degree of utilization, but systematic analyses showing the extent and variability of
implementation across sites are lacking. Meanwhile, substantial and variable backsliding in BP control rates
across health systems was documented at the onset of the pandemic, and it is unclear how much of the
variability is driven by differential implementation of new BP-related technologies and strategies.
To learn from this unprecedented natural experiment and help guide the US healthcare enterprise
towards more effective and equitable practices for management of BP control, we propose a mixed methods
comparative effectiveness analysis. We will leverage our nationally scoped PCORnet Blood Pressure Control
Laboratory (BPCL) – designed fundamentally for efficient surveillance of BP control and related process
metrics using electronic health record (EHR) data – to develop and validate process metric queries that track
implementation of new BP-related technologies & strategies, field these queries along with our previously
developed metrics, extract trend results and individual patient-level data from participating sites, and conduct
descriptive and causal inference analyses to decipher successful patterns of care for uncontrolled BP. And, we
will conduct a positive deviance analysis with mixed methods approach to assess residual variability in BP
control across clinics and learn from clinics with unexplained excellence. Our specific aims are to: 1) evaluate
time trends and disparities in utilization of BP-related telehealth and home BP monitoring; 2) estimate causal
effects of telehealth implementation on BP control and related metrics in hypertension management; and, 3)
identify clinics with unexplained resilience in BP control and use mixed methods to analyze potential
mechanisms and opportunities for dissemination of effective, scalable practices. As we have done in prior
work, we will test for effect heterogeneity across important subgroups (sex, race, ethnicity) and place special
emphasis on BP control in non-Hispanic Black patients, for whom disparities are historically largest. Findings
from these aims will be discussed with stakeholders via webinar including a panel of frontline clinicians and
leaders from positive deviant clinical sites, and disseminated via conference presentations and publications.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic caused major disruptions in health care processes, accelerating use of newer technologies like telehealth and self-monitoring of blood pressure, both of which have been recommended for managing hypertension but not extensively used. This project will assess the extent and variability in implementation of these newer technologies across care settings, the effects of such implementation on blood pressure control and related processes, and seek to understand what allowed some healthcare settings, so called “positive deviants,” to have particularly resilient responses to managing blood pressure during the pandemic. Findings from this study will help guide the US healthcare enterprise towards more effective and equitable practices for management of blood pressure control, including whether and how these newer technologies should continue to be reimbursed.